STEM Assessment and Reporting Tracker (START): Professional portfolio mentoring to support workforce training and longitudinal outcomes research

PROJECT SUMMARY
This one-year administrative supplement requests funds to expand mentorship of current and past trainees
working on SEPA-funded research projects (Goal 1). This supplement develops an interprofessional student
mentoring core around research project outcomes and focuses on professional portfolios to extend
deliverables of our parent award (Goal 2). This administrative supplement aligns directly with our SEPA parent
grant that is developing the STEM Assessment and Reporting Tracker (START), a robust online evaluation tool
for engaging students with immediate, tailored e-feedback aimed at supporting their STEM development while
rapidly informing STEM programs' efforts. Work this year has highlighted inclusive demographics as a key area
of work for the tool, which is being expanded through this supplement to provide further education and
guidance for STEM and biomedical research training programs. START is overseen by Institutional Review
Board (IRB #22889), which enables collection of professional portfolios for future research on longitudinal
outcomes tied to students’ STEM development as well as sharing to support workforce training. This
supplement supports trainees’ research development with outcomes geared toward professional portfolios,
which has feed-forward research that accelerates goals of the parent project by identifying repository
structures, sharing permissions, and advisory governance for collecting and disseminating research-related
professional portfolios used to define STEM outcomes. This supplement mentors trainees in developing
preliminary structures for a Trainee Writing Core, Data Management Core, and a Trainee Advisory Board.
Together, this project aims to enhance students' STEM development and persistence by supporting STEM
programs in the measurement, immediate analyses, and rapid reporting of psychosocial factors that support
students' success in STEM while enabling collection of trainee documentation that supports outcome
measurement.

Public health relevance
PROJECT NARRATIVE This supplement develops an interprofessional student mentoring core around STEM Assessment and Reporting Tracker (START) project outcomes and focuses on professional portfolios to extend deliverables of our parent award focused on biomedical workforce development. Trainees will receive mentored research training to develop preliminary infrastructure for a Trainee Writing Core, Data Management Core, and a Trainee Advisory Board. This supplement accelerates goals of the parent project by identifying repository structures, sharing permissions, and advisory governance for collecting and disseminating research-related professional portfolios used to define STEM outcomes within START.